Mechanisms of T Cell Memory Quiescence

ABSTRACT (COVID-19 SUPPLEMENTAL RESEARCH)
During fast-spreading disease outbreaks (such as the present COVID-19 pandemic), quick induction of
herd immunity through vaccination is critical. Currently there are many SARS-CoV2 candidate vaccines in
various stages of clinical development, aimed at inducing robust multimodal protective immunity comprising
both long-lived antibody and memory T cells. However, we have little control over how quickly protective
immunity may be established following immunization. At the very minimum, vaccine-induced T cells require a
period of ~20-30 days of antigenic rest after initial immunization to effectively downregulate their effector
program and convert into quiescent, functionally potent, long-lived memory cells poised at portals of pathogen
entry. If vaccine-induced T cells are re-exposed to antigen during this mandatory rest period – as might occur
in case of exposure to virulent pathogen during an outbreak – the quantity, quality and overall protective
efficacy of immune memory are significantly jeopardized. Hence, shortening the window of immune memory
development is a key goal during vaccination, and is of high significance during pandemics to establish
accelerated protection in frontline healthcare and essential service providers, and speed up herd immunity in
the general population for expedited return to normalcy and economic growth.
In this administrative supplement, we will evaluate candidate immunomodulatory strategies to accelerate and
enhance vaccine-induced protective T cell memory to SARS-CoV2 by facilitating Treg-aided effector-to-
memory conversion. This work is based on our studies establishing a critical role of Tregs in promoting
effector-to-memory conversion through CTLA4, an inhibitory molecule most highly expressed on Tregs
(amongst all immune cells) (Immunity, 2015). Importantly, soluble CTLA4 administered in trans, is alone able
to fully supplement the function of Tregs in memory differentiation, and accelerates the formation of protective
anti-viral immunity by promoting the metabolic switch necessary for effector-to-memory conversion. These
proof-of-concept studies in models of viral immunity (conducted under the aegis of past R21, and parent R01
awards) lay a strong foundation for enhancing SARS-CoV2-specific immune memory following immunization
with candidate SARS-CoV2 vaccine in preclinical murine model. These studies represent a natural
translational extension of the parent R01 focused on mechanistic and molecular details of Treg-dependent
memory enhancement through CTLA4 in model viral infections. Importantly, CTLA4-Ig is FDA-approved Phase
III drug – ready for clinical translation. Therefore, immediate impact on our ability to quickly establish herd
immunity against SARS-CoV2 is expected. In addition to addressing the current COVID-19 exigency, these
studies are also relevant to other pandemics and situations of urgent vaccination of our defense troops for
quick deployment to disease endemic areas.

Public health relevance
PUBLIC HEALTH RELEVANCE (COVID-19 SUPPLEMENTAL RESEARCH) Vaccination is one of the most effective biomedical tools against infectious diseases such as SARS, AIDS, tuberculosis, HCV, and malaria. Enabling faster and better development of protective immunity following vaccination is important in case of pandemics and epidemics, and also in situations where urgent travel to disease-endemic areas is needed. Identification of agents that can augment vaccine-induced immunity will have significant impact on the public health and economic burden associated with the current COVID-19 pandemic, and other future outbreaks of public health relevant diseases of bacterial, viral and parasitic etiologies.